Neural mechanisms of successful intervention in children with dyslexia

Reading instruction prompts the emergence of neural circuits that are specialized for rapidly translating printed
symbols into sound and meaning. Understanding how these circuits differ in children with dyslexia, and change
with learning, is an important scientific challenge that holds practical implications for education. The proposed
research employs longitudinal measurements in children with dyslexia over the course of a highly effective
intervention program to: (a) determine how brain structure and function change in response to reading
instruction; and (b) investigate neurobiological factors that predispose a child to struggle or succeed in the
intervention. Thus, this proposal seeks to determine both how education shapes brain development, and how a
child’s unique neurobiology predicts educational outcomes.
Aim 1) White matter plasticity and learning – White matter was previously considered static infrastructure; it
is now known that many cellular properties of the white matter change with learning. Reading interventions
provide a powerful tool to study experience-dependent plasticity in the human brain. Based on novel
quantitative MRI and diffusion MRI measurements developed by the PI and collaborators, it is now possible to
quantify changes in cell density, intra-axonal water and myelination at millimeter resolution. Longitudinal
measurements collected before, during, and after the intervention will be used to model the time-course of
white matter plasticity associated with improvements in reading skills, and investigate the biological
mechanisms that underlie differences in learning among children.
Aim 2) Bottom-up and top-down computations in the reading circuit - When our eyes fixate upon a word,
a cascade of neural processes is initiated, beginning in the visual system and progressing through a series of
computations that translate the visual representation into sound and meaning. We have developed the first
model of the neural computations performed by critical components of the brain’s reading circuitry. Based on
this new understanding of computations in the literate adult brain, we will investigate how computations differ in
children with dyslexia, and change in response to reading instruction.
Aim 3) Neural biomarkers of learning outcomes - Even in a controlled and intensive learning environment,
some children show substantial improvements in reading skill, while others show limited change. What
biological factors predispose a child to excel or struggle when provided a high-quality intervention? Pre-
intervention MRI measurements will be examined as predictor variables for individual differences in
intervention learning rate, and long-term, post-intervention outcomes. Aim 3 will capitalize machine learning to
develop a model of the neuroanatomical factors that predict learning outcomes.

Public health relevance
Dyslexia, an impairment in accurate or fluent word recognition, is the most common learning disability affecting roughly ten percent of children. This proposal capitalizes on cutting edge neuroimaging methods, in combination with carefully controlled educational interventions and behavioral measurements, to generate a new understanding of how successful intervention shapes the development of the brain circuits that support skilled reading. A deeper understanding of the mechanisms of successful remediation of dyslexia, and individual differences in learning, will pave the way for personalized approaches to dyslexia treatment.